Genome Maintenance via the BRCA-RAD54 Axis

ABSTRACT
Homology-directed DNA repair (HDR) is a universal, conserved mechanism for the repair of DNA double-
strand breaks and the maintenance of DNA replication forks. While HDR is relatively well understood in
bacteria and lower eukaryotes, glaring knowledge gaps remain in the appreciation of mechanisms in
mammals, because of greatly added complexity including myriad factors that are unique. Notably, several
breast and ovarian tumor suppressors, including BRCA1-BARD1, BRCA2, and PALB2, have been implicated
in HDR in mammals, and emerging evidence provides glimpses of the roles that they fulfill. However, a holistic
understanding the molecular mechanisms of human HDR has been hampered by the immense challenge of
expressing and purifying these very large proteins and protein complexes for mechanistic workup. My
laboratory has overcome this challenge, allowing us to demonstrate the pivotal role of BRCA2 in complex with
its obligatory partner DSS1 in facilitating the assembly of catalytically active filaments of the RAD51
recombinase on single-stranded DNA and to reveal a late role of the BRCA1-BARD1 complex in HDR via the
promotion of RAD51-mediated DNA strand invasion. In this proposal, we aim to fill several knowledge gaps
regarding how BRCA1-BARD1, BRCA2-DSS1, and PALB2 synergize in two distinct stages of the HDR
process. Specifically, we will apply an integrated approach that encompasses reconstitution biochemistry,
single-molecule biophysics, structural biology, DNA fiber analysis, and advanced cell biology to interrogate
how the aforementioned tumor suppressors and their partner HDR factors, such as RAD54, help promote the
assembly of the RAD51-ssDNA nucleoprotein filament and the catalysis of DNA strand invasion within the
context of chromatin. The results from our work will bring molecular and mechanistic clarity to RAD51-
dependent HDR and the preservation of stressed DNA replication forks in human cells.

Public health relevance
NARRATIVE BRCA1-BARD1 and BRCA2 are involved in DNA double-strand break repair and replication fork preservation by homology-directed DNA repair (HDR). Our research project strives to elucidate the functions of these factors and their associated HDR partner proteins in the execution of key HDR stages. This is now possible because we have developed robust systems to obtain highly quality protein preparations for mechanistic workup. As such, we are well positioned to leverage our expertise in biochemistry, biophysics, structural biology, and cell biology to fill knowledge gaps regarding HDR mechanisms and regulation in human. The information that will emanate from our work has strong health relevance, as DNA repair deficiency is associated with aging, neurological disorders, infertility, and cancer.